Duke Testing Site for Stroke Preclinical Assessment Network

Abstract
Stroke is a severe medical condition that affects about 800,000 in the United States every year, and 87% of
these strokes are ischemic. Recent advances in mechanical thrombectomy have substantially increased the
number of acute ischemic stroke patients who are eligible for reperfusion therapy. To further improve stroke
outcome, there is an urgent need to identify effective cerebroprotective interventions as adjunct treatments to
reperfusion therapy after ischemic stroke. Indeed, the NINDS Stroke Preclinical Assessment Network (SPAN)
has called for highly promising cerebroprotective interventions to be simultaneously tested in multi-site preclinical
settings before advancing to clinical trials. The goal of this application is to participate in SPAN as a testing
laboratory to assess the efficacy of interventions selected by SPAN to improve long-term stroke outcome. As a
preclinical testing site, we will perform our assessments in transient ischemic stroke animals in a controlled,
randomized, and blinded fashion, following the standard protocols developed with NINDS and the SPAN
Coordinating Center (CC). We have assembled a strong Duke University investigative team from 4 departments
that includes basic and clinical stroke scientists, neurologists, neuroradiologists, behavior scientists, and
biostatisticians, and that has had an excellent preclinical stroke research record for over 2 decades. The team
has well established stroke models that meet the needs of long-term preclinical testing with consideration for
relevant biological variables such as sex and age, as well as ischemic stroke-related comorbidities. Multiple
quantitative behavioral tests and advanced MRI imaging are in place to support clinically relevant outcome
assessments. Collectively, this team has the experience, knowledge, skills, and equipment required to join SPAN
as a well-qualified testing site. The Duke site also has a scientific, administrative, and institutional commitment
to collaborate with the CC, other sites, and intervention providers for in-parallel testing of up to 8
cerebroprotective interventions and timely data sharing and reporting. We expect to find that the most promising
interventions, identified by SPAN, can be advanced into clinical trials, and bring hope to stroke patients.

Public health relevance
Public Health Relevance Statement The proposed research is relevant to public health because this project will evaluate cerebroprotective effects of promising therapeutic interventions in ischemic stroke. This is relevant to the NIH’s mission because knowledge obtained from the proposed research will be the basis for potential clinical trials to improve long-term neurologic function of stroke survivors, which will advance the Nation’s capacity to protect and improve health.